Impact of obesity on SARS-CoV-2 infection and reciprocal effects of SARS-CoV-2 on metabolic disease

The COVID-19 global pandemic caused by the novel SARS-CoV-2 coronavirus continues to result in
significant morbidity and mortality worldwide. Although effective vaccines and therapeutics have been
introduced, COVID-19 will continue to persist as a public health issue as a result of vaccine
resistance/hesitancy and risk of reinfection, the emergence of variants of concern that may evade current
vaccines, and the potential existence of latent viral reservoirs. The adverse outcomes associated with COVID-
19 are increased by a number of pre-existing conditions, notably diabetes, cardiovascular disease, and
hypertension. These conditions share obesity and insulin resistance (IR) as a common underlying feature,
which has raised the question of whether obesity per se is an independent risk factor for more severe COVID-
19 outcomes in the absence of clinically diagnosed diabetes, cardiovascular disease, or hypertension. This
concept is supported by previously described effects of obesity on respiratory disease and the immune
response. Evidence is also accumulating for altered glucose and lipid metabolism and new-onset diabetes in
COVID-19 patients that can persist after recovery from acute infection, and that constitutes an important
component of post-acute sequelae of COVID-19 (PASC). These data suggest that, while obesity and metabolic
disease affect the acute COVID-19, that there are a reciprocal acute and post-acute effects of COVID-19 on
metabolic control. We hypothesize that: (1) obesity/IR in the absence of other conditions such as frank
diabetes, CVD, or hypertension will increase the severity of SARS-CoV-2 infection and acute disease
pathology; and (2) that SARS-CoV-2 infection will exacerbate pre-existing preclinical metabolic disease as
reflected in progression to more advanced, clinically evident disease. We propose to address these
hypotheses through pursuit of the following specific aims.
Specific Aim 1. Determine the effect of pre-existing obesity/IR on the acute response to SARS-CoV-2 infection.
Specific Aim 2. Determine the effect of SARS-CoV-2 infection on the post-acute progression of metabolic
disease.
We will employ a nonhuman primate preclinical model of lean, metabolically healthy and obese, insulin-
resistant adult male rhesus macaques infected with SARS-CoV-2 over a 2-week (acute phase) or 6-month
(post-acute) course of disease, during which time comprehensive longitudinal assessments of viral load, lung
pathology, peripheral and adipose immune cell responses, and glucose and lipid metabolism will be performed.
At necropsy following the acute and post-acute studies, islet function will be assessed and multiple tissue
samples collected for determination of viral distribution and persistence in potential latent reservoirs. The
proposed studies represent a unique opportunity to elucidate the mechanisms underlying the reciprocal
relationship between COVID-19 and metabolic disease in an experimentally tractable preclinical model.

Public health relevance
Narrative Pre-existing conditions such as diabetes, heart disease, and high blood pressure, which share underlying obesity, increase the severity of COVID-19. Conversely, patients with COVID-19 often present with newly- diagnosed diabetes, or develop diabetes and other aspects of metabolic disease after recovering from COVID- 19. This project will investigate this two-way relationship between COVID-19 and obesity using a nonhuman primate model, since the nonhuman primate response to the SARS-CoV-2 coronavirus and to obesity is similar to humans.